Iowa Flexible Funding Model Application

Project Abstract
This cooperative agreement is intended to support the Manufactured Food Regulatory Program
Standards (MFRPS), Rapid Response Team (RRT), and Food Protection Task Force (FPTF) Program, as well
as a Special Project supporting MFRPS. The intended outcome of this FOA is to advance efforts for a
nationally integrated food safety system (IFSS) by assisting state programs in maintaining conformance
with the MFRPS, supporting a Food Protection Task Force, and enhancing an integrated food safety
system by further coordinating resources between the FDA and State for special projects.
The Iowa Department of Inspections and Appeals (DIA), Food and Consumer Safety Bureau licenses and
inspects approximately 501 food manufacturing facilities, 555 food warehousing facilities, and 22,000
retail food establishments including restaurants and grocery stores. DIA has dedicated Manufactured
Foods Program responsible for manufactured food licensing, compliance, and inspection activities. The
MFRPS will have a dedicated person to lead all standard’s activities.
The DIA, as part of this application, will maintain an all-hazards human and animal food (HAF) program
that will collaborate with other RRTs and FDA. The mission of the RRT will be to effectively respond to
HAF incidents and support all objectives of the 5 Year Plan. In addition, DIA will retain a FPTF where all
key food safety stakeholders can hold a forum to share information and promote integration through
collaboration. Furthermore, DIA will complete a special project that creates mutual reliance with FDA in
support of MFRPS.

Public health relevance
Project Narrative The Iowa Department of Inspections and Appeals (DIA), Food and Consumer Safety Bureau intend to maintain implementation and conformance with the Manufactured Food Regulatory Program Standards (MFRPS) and ensure that continuous improvement of standards is documented. Iowa also seeks to maintain a Rapid Response Team (RRT) by supporting all listed priorities in the 5 Year Plan. Also, Iowa intends to maintain a Food Safety and Protection Task Force that provides a forum for stakeholders to share information and promote integration through collaboration. Lastly, DIA will complete a Special Project that creates mutual reliance with FDA in support of MFRPS.